PULMONARY ELASTIC FIBER DEGRADATION IN PARAQUAT TOXICITY

Peroxidase-labeled and ferritin-labeled antibodies were used for the light and electron microscopic localization of elastin in lungs of monkeys with paraquat toxicity.